GLYCOEPITOPES IN PANCREATIC LINEAGES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This project involves the characterization of glycoepitopes on hESCs, hiPSCs, definitive endoderm, foregut endoderm, and pancreatic endoderm derived from human pluripotent cells. Cells will be prepared by Novocell (San Diego) and analyzed by the Dalton lab. This will initially involve lectin screening by flow cytometry.